Localized Chelation Therapy for Removing Calcification in PAD

PROJECT SUMMARY
Peripheral artery disease (PAD) leads to high morbidity, mortality, and diminished life quality, with arterial
calcification substantially increasing the risk of treatment failure and quadrupling the likelihood of amputation.
Currently, there are no effective ways of removing arterial calcification. One potential therapy involves disodium
ethylenediaminetetraacetic acid (EDTA), a chelating agent, but its systemic use in doses high enough to be
effective in the vasculature causes severe side effects. We propose a novel method of delivering EDTA directly
to calcified lesions using a microneedle catheter and hypothesize that local EDTA chelation removes arterial
calcium, reduces inflammation, and improves limb flexion hemodynamics while avoiding systemic side effects.
To test this hypothesis, we will leverage our expertise in evaluating over 1,000 human lower extremity arteries
with various types of calcification, and our novel preclinical large animal model that recapitulates arterial
calcification observed in human vessels. This will be achieved through two aims. First, we will use our unique
biobank of calcified human FPAs from tissue donors and amputated lower extremity arteries to develop a local
EDTA chelation strategy to reduce or resolve calcific lesions in a burden, time, and dose-dependent manner.
We will use donor tissues to assess EDTA delivery location, distribution, tissue integrity, and drug kinetics, and
employ live calcified amputated human specimens and healthy animal explants to test therapeutic EDTA levels,
measuring myogenic tone, metabolic activity, cellularity/confluency, and endothelial function in biomimetic
culture. Second, we will employ our novel swine model of peripheral artery calcification to determine the safety
and effectiveness of local EDTA treatment. Bilateral femoral artery calcification will be induced in Ossabaw swine
on an atherogenic diet using an intravascular CaCl2 injection delivered via a microneedle catheter. Imaging will
assess baseline arterial pulsatility, and measurements in straight and bent limbs will assess the influence of
calcification on arterial biomechanics and flow as a result of limb flexion. Calcific lesions will then be treated with
locally-delivered EDTA tuned to a specific calcium burden, while the contralateral calcified artery will serve as a
control. Monthly imaging will assess changes in pulsatility, bone density, arterial calcium levels, and
hemodynamics in various limb positions. After sacrifice, μCT will determine the extent and pattern of calcification,
mechanical tests will evaluate arterial compliance, and histological and immunohistochemical analyses of
arteries and kidneys will assess cellular and matrix structure, repair, and toxicity. Our large animal model
accurately replicates the primary characteristics of peripheral artery calcification, enabling the use of human-
sized devices within a rigorously controlled environment. By integrating it with a unique collection of calcified
human arteries from our laboratory, we aim to develop localized strategies for the safe and effective removal of
arterial calcium, improving clinical outcomes for patients with PAD. This novel approach is set to transform clinical
practices by offering a viable treatment for a condition that currently lacks effective therapeutic options.

Public health relevance
PROJECT NARRATIVE Peripheral Artery Disease (PAD) affects millions, increasing the risk of amputation and reducing quality of life, especially in patients with arterial calcification. There is currently no effective method to remove arterial calcium, but our project aims to develop a novel EDTA delivery system to target and dissolve it. By testing this approach on human artery specimens and a swine model, we hope to introduce a new treatment for calcific PAD that could reduce the disease’s burden and improve patient outcomes.